Vertebrate Non-Coding RNPs: Integrating function, biogenesis and survival

DESCRIPTION (provided by applicant): Vertebrate cells employ a litany of non-coding RNAs (ncRNAs) to orchestrate and regulate the synthesis of proteins. In addition to the transfer RNAs and ribosomal RNAs that decode messenger RNAs in the cytoplasm, ncRNAs are involved in the earliest steps of gene expression in the nucleus: long ncRNAs modulate chromatin structure and thus transcription, while two sets of small nuclear RNAs (snRNAs) are the building blocks of the major and minor spliceosomes that remove both constitutively- and alternatively-spliced introns from pre- mRNAs. Even the 32-end formation of histone mRNAs requires the U7 snRNA. These essential ncRNAs themselves undergo covalent modification directed by yet other classes of ncRNAs during their biogenesis in the nucleus: small nucleolar RNAs (snoRNAs) and small Cajal body RNAs (scaRNAs) guide the specific introduction of 22-O-methyl and pseudoU residues into rRNAs and snRNAs, respectively. Once exported to the cytoplasm, mRNA translation and stability are regulated by microRNAs, the newest class of ncRNAs, which undergo regulated processing steps in both the nucleus and the cytoplasm during their biogenesis. All of these ncRNAs act in conjunction with bound proteins, forming ncRNPs, to execute their functions. The proposed research will continue to discover novel ncRNP functions and protein interactions that underlie the biogenesis and stability of ncRNAs, particularly in the vertebrate cell nucleus. Specifically, a novel chaperone function for a scaRNA in assembling the U2 snRNP will be investigated. Our discovery that the core RNA helicase component (eIF4AIII) of the exon junction complex has a second conserved role in ribosomal RNA biogenesis will be confirmed. The probable existence of additional eIF4A/eIF4G-like pairs will be explored and their contributions to critical steps in gene expression assigned. Phosphoproteomics and single-molecule approaches will complement functional studies of the core components of the Microprocessor-Drosha and DGCR8-to uncover the molecular basis of regulation of pri-microRNA processing in the nucleus of tumorigenic versus non-tumorigenic cells. RNA elements that confer stability on nuclear long noncoding RNAs will be identified bioinformatically and characterized both biochemically and structurally. Nucleases participating in rapid RNA decay in the nucleus will be identified, and their possible localization in nuclear bodies will be investigated using single-molecule live-cell imaging techniques. Together, this understanding will contribute to the development of therapeutic approaches to combat multiple genetic diseases that derive from faulty RNA processing and surveillance, as well as cancer.

Public health relevance
Some RNA molecules do not serve as messages for making proteins but nonetheless play essential roles in the production of the cell's repertoire of proteins. Recently, additional kinds and novel functions of such "noncoding RNAs" have been recognized, underscoring their importance in regulating the production of cellular proteins. Our exploration of the contributions of noncoding RNAs will provide novel insights into potential targets and therapeutic mechanisms for combating a multitude of devastating genetic diseases including muscular dystrophy, spinal muscular atrophy and cancer.